Functionally Validated Structural Endpoints for Early AMD

ALSTAR2 (R01EY029595) is a prospective cohort study of older adults in normal retinal health and those with
early and intermediate age-related macular degeneration (AMD). AMD is the leading cause of irreversible
vision impairment in older adults in the US and affects about 170 million people worldwide. The retina has the
same embryological origin and development as the brain, providing a unique, non-invasive approach for
evaluating brain conditions including Alzheimer’s disease and mild cognitive impairment (MCI). Associations
between AMD and Alzheimer’s disease have been shown in several epidemiologic studies to date. AMD and
Alzheimer’s disease both are characterized by neurodegeneration and share advanced age and smoking as
risk factors. In addition, Alzheimer’s disease and AMD have common features such as microangiopathy,
chronic inflammation, and amyloidß. However, the shared mechanistic pathways between these two prevalent
diseases remain unknown. Most studies on retinal biomarkers for MCI and Alzheimer’s disease have excluded
persons with concurrent retinal disease including AMD. There has never been a large, well-powered,
prospective study on Alzheimer’s disease that has explicitly by design included people with AMD. In ALSTAR2,
we are examining the structural biomarkers of early AMD associated with visual function decline. These same
participants are also at risk for Alzheimer’s disease and MCI due to advanced age. We just completed baseline
ALSTAR2 enrollment (N=546), with large numbers of persons with early AMD, intermediate AMD, and those in
normal retinal health. The three-year follow-up will begin in early 2023, repeating the entire baseline ALSTAR2
protocol. At that follow-up visit we will leverage ALSTAR2’s unique dataset by adding cognitive testing and
neuroimaging through an R01 application we will submit in 2022. Thus we will not only have retinal microscopic
structure and microvasculature imaging through multimodalities and visual functional biomarkers, but we will
also have a simultaneous examination of neuroimaging of cerebral structure and vasculature and cognitive
function. We will be well-positioned to identify structural abnormalities (e.g., lipidic depositions) and vascular
characteristics in retina and brain as a function of cognitive function (e.g., MCI). To prepare for this R01
application, which will also add a six-year follow-up, we plan this supplement to study 60 new participants from
normal macular health to intermediate AMD, many of whom have MCI. The goal of this supplement is to
develop pilot data on neuroimaging, cognitive function, retinal imaging, AMD disease severity, and functional
biomarkers for AMD to generate guidance on statistical power for the R01 submission and to establish
neuroimaging and cognitive testing feasibility. In this supplemental study we will examine the associations of
(1) structural abnormalities in retina and brain with cognitive dysfunction, (2) retinal and cerebral
microvasculature metrics with cognitive dysfunction, and (3) AMD status and visual function biomarkers with
cognitive dysfunction.

Public health relevance
ALSTAR2 is a prospective cohort study of older adults in normal retinal health and those with early and intermediate age-related macular degeneration (AMD) with the goal of developing retinal structural endpoints that are validated by visual function. The retina has the same embryological origin and development as the brain, providing a unique, non-invasive approach for evaluating the risk for mild cognitive impairment (MCI) and Alzheimer’s disease. Here we propose to add evaluation of cognitive function and extensive neuroimaging to ALSTAR2 to guide statistical power calculations for a new R01 assessing the relationship between aging brain and aging retina at ALSTAR2’s three-and six-year follow-up.